Studies Of The Hiv Protease, Reverse Transcriptase, and Integrase

In this year we devoted extensive effort to the development of improved force fields that can interface seamlessly with quantum chemical methods, in particular Density Functional Theory, to study the reaction mechanisms HIV-1 macromolecules. Due to the high concentration of charged amino acid and nucleic acid residues, as well as the presence of metal ions, the treatment of short ranged and long ranged electrostatics is critical to achieving reliable results. We have also initiated an effort to develop an all-atom model for the HIV-1 Integrase system, for which an x-ray crystal structure became available within the past year.